A genetically encoded toolset to decipher the biology of post-translational modifications in the mammalian proteome

Project Abstract
Post-translational modifications (PTMs) dramatically expand the chemical and functional space accessible
to proteins. Over the last 25 years, the landscape of known PTMs within the mammalian proteome has
expanded at a dizzying speed, driven by the remarkable advances in mass-spectrometry based proteomics.
However, functional consequences of most of these PTMs remain poorly characterized. At the core of this
deep knowledge-gap – on a critically important facet of our biology – lies the difficulty of homogeneously
generating eukaryotic proteins carrying a desired PTM at chosen site(s) to study how the presence of the
modification alters the protein’s properties in vitro and in cellulo. For most PTMs, the precise biochemical
origin is either poorly understood or challenging to reconstitute without additional pleiotropic consequences.
The noncanonical amino acid (ncAA) mutagenesis technology, enabled by genetic code expansion (GCE),
provides an exciting solution for this problem by enabling site-specific incorporation of a modified residue
into virtually any site of any protein expressed in living cells. However, application of this technology in
mammalian cells has faced significant technical limitations, including restricted structural diversity of ncAAs,
inefficient incorporation, and difficulties in extending it to hard-to-transfect cells. Over the last five years, we
have systematically addressed these challenges by: A) Establishing new platforms to incorporate new
structural classes of ncAAs, B) Developing a mammalian cell-based directed evolution platform to engineer
the ncAA-incorporation machinery, C) Creating optimized expression systems and delivery vectors for
efficient ncAA incorporation in diverse mammalian cells and tissues. These advances have already enabled
us to model several new PTMs in mammalian cells, including tyrosine sulfation and phosphorylation, arginine
citrullination, dual acetylation/methylation of lysine, serotonylation of glutamine, etc. In the next five years,
we will continue our quest to expand the scope of this technology for modeling an even larger subset of
important PTMs associated with the mammalian proteome. Additionally, using our novel mammalian cell-
based directed evolution platform, we’ll systematically optimize the ncAA incorporation machinery to improve
its scope and robustness. Finally, using our powerful new ability to site-specifically introduce previously
inaccessible PTMs into proteins expressed in mammalian cells, we will develop novel approaches to study
several different facets of their biology: 1) Characterize the unique interactome of a PTM-labeled protein
(using proximity labeling/MS-proteomics). 2) How PTMs alter the conformational dynamics of complex
mammalian proteins (using single-molecule FRET). 3) How certain PTMs enhance the immunogenicity of
human proteins (using novel display strategies). In addition, the research proposed here will fundamentally
advance the scope of the GCE technology for application in higher eukaryotes for numerous additional
applications, which will have broad and deep impact beyond the scope of this proposal.

Public health relevance
Project Narrative We propose to develop technology for modeling a wide variety of novel post-translational modifications of proteins found in eukaryotic cells with high accuracy and versatility. Using this technology, we aim to understand the roles of these post-translational modifications in human health and diseases, such as autoimmune disorders and cancer.